Intercellular Communication in Retinal Development

Project summary/abstract
Using serial block-face scanning electron microscopy, we have produced the first adult mouse
retinal volume that spans the entire depth of the retina, from photoreceptors to the nerve fiber
layer at nanometer resolution to map mouse retinal cell types and their microcircuits. There are
currently no other mouse retinal volumes that encompass both the inner and outer retina.
Cellular ultrastructure and synaptic detail are excellent. Based on this volume, our goal is to
provide the community with the most complete first-draft connectome of the mouse retina
available anywhere within about a year. To achieve this, we propose to use Scalableminds
Voxelytics services to stitch together and register the images, then segment the entire volume
and detect ribbon and conventional synapses. These services will accelerate the availability of a
fully segmented volume of the mouse retina that will greatly benefit ongoing retinal circuitry
projects as well as facilitate new discoveries by the community.

Public health relevance
Project Narrative The vertebrate retina comprises many microcircuits working together to process information necessary for us to navigate the visual world. Although we have a good understanding of some key circuits, many others remain elusive. This is because there has not been an opportunity to map all cells and their detailed connectivity within a retina. This project will enable labs to work collaboratively to generate a complete connectome of an adult mouse retina, a key model system for studying visual processing and for understanding how cellular and circuit perturbation, such as loss of photoreceptors and their connections, contribute to vision loss.